From proteomics and genomics to therapeutics in systemic sclerosis interstitial lung disease

Lung involvement in systemic sclerosis (SSc) is common, occurs more frequently in SSc than in other connective
tissue diseases and is its leading cause of death, manifesting as interstitial lung disease (ILD) or pulmonary
arterial hypertension (PAH). Only two Food and Drug Administration (FDA)-approved compounds (nintedanib
and tocilizumab) have been shown to slow the decline of lung function in SSc-ILD, but do not stop or reverse the
progression of SSc-ILD. This highlights an unmet medical need for improved molecular understanding of SSc-
ILD pathogenesis for identification of novel targets for drug development. SSc-ILD is thought to be triggered by
immune-mediated microvascular injuries that induce and perpetuate inflammation, autoimmune responses, and
fibroblast-to-myofibroblast activation with subsequent collagen deposition ultimately leading to lung fibrosis. We
have recently provided the largest known lung proteome in human and mouse, encompassing more than 8000
proteins, uncovering novel druggable mediators and cell types driving lung fibrosis. We have identified several
shared mediators of fibrosis (e.g., the SMAD3/TGF-beta pathway) between SSc skin lesions and IPF lung tissue.
An accurate quantification and characterization of the SSc lung proteome, however, remains to be performed.
Using novel technological advances, we propose to define and quantify the intricate composition of the fibrotic
SSc lung and uncover components within the lung proteome that will serve as peripheral biomarkers and/or drug
candidates for the monitoring and treatment of SSc-ILD, respectively. The overarching goal of this application is
1) to define, in greatest detail, the molecular composition of the SSc-ILD lung and peripheral blood, 2) to
identify novel disease-specific network modules and mechanisms of tissue fibrosis for improved drug
development, and 3) to uncover proteins that can serve as diagnostic, prognostic, or predictive
biomarkers for SSC-ILD. We hypothesize that the SSc lung proteome identifies SSc-specific druggable cues,
produced by resident fibroblasts, that drive persistent lung fibrosis. We will define and quantify changes in the
composition of the proteomes of the lung and blood of SSc-ILD patients that correlate with disease
severity in cross-sectional and longitudinal cohorts of SSc-ILD patients. We will provide the SSc-ILD lung’s
epigenetic landscape and transcriptome at single cell resolution by performing gene expression and open
chromatin accessibility assays using Chromium single multiome ATAC + Genome Expression analysis in nuclear
preparations of lung cell suspensions. Finally, we will use a novel drug screening platform of TGF-beta-
induced Smad translocation in SSc-derived primary fibroblasts, and characterize inhibitors of the class
III phosphatidylinositol-3-kinase (PI3K) vacuolar protein sorting 34 (Vps34) as novel targets for the
inhibition of lung fibrosis. We will work closely with the other CORT cores and projects to generate novel data
on common and specific drivers of SSc-ILD for the identification of new druggable targets underlying the
pathobiology of fibrotic pathways in SSc-ILD.